PROLEASE HGH IN CHILDREN W/ GROWTH FAILURE DUE TO GROWTH HORMONE DEFI

The study will investigate the long-term safety and efficacy of a new sustained release formulation of recombinant human growth hormone, ProLease hGH, produced by Alkermes, Inc.